INRSA Training Grant in Gastroenterology

PROJECT SUMMARY/ABSTRACT
Training creative and productive investigators in gastrointestinal research is the central mission of our program.
Emerging discoveries in human genetics, epigenetics, molecular and cellular biology, single cell sequencing
technologies, microbiology, immunology, and epidemiology have had major impacts on the understanding of
pathophysiology of gastrointestinal diseases. Accordingly, our T32 program is focused on training MD,
MD/PhD, and PhD investigators in basic and clinical research in the pathophysiology of GI diseases. During
This funding cycle, we have successfully recruited investigators from diverse personal and professional
backgrounds. This supplement is intended to provide support for one of these talented trainees.

Public health relevance
Project Narrative This application is for support of three training positions in an established program in digestive diseases that has been funded since 1975 at the Division of Gastroenterology, University of California, San Francisco. The Program’s goal is preparing trainees for careers in academic luminal gastroenterology, and its track record in this regard is outstanding, with numerous graduates of the program now in leadership positions. These talented individuals are well poised to capitalize on the exciting state of GI related research, with its transformative and translational potential.